Engineering Cationic Metallopolymers to Potentiate Antibiotics via Multiple Mechanisms

Abstract
Polymeric biomaterials play a significant role in modern biomedical sciences, including the
application of being used as antimicrobial agents. Bacterial infections have evolved into one of
the most urgent global health threats, leading to increased healthcare cost, destruction of local
tissues, patient disability, morbidity, and even death. Antibiotics, one of the most important
developments in modern medicine, have saved millions of lives and continue to serve as the
major therapy to treat bacterial infections. However, commonly-used antibiotics have diminished
antimicrobial efficacies and/or are ineffective against numerous multidrug-resistant (MDR)
bacterial pathogens. If more-effective strategies are not taken to prevent and treat bacterial
infections, it has been predicted that by 2050 infections could claim 10 million lives with costs
approaching $100 trillion (USD) dollars worldwide. Facing the mounting crisis on the rise of
antibiotic-resistant bacteria, it is essential for innovating the continued use of existing antibiotics
and for establishing a more sustainable portfolio of new antimicrobial therapies.
We propose to develop platform biointerfaces technologies on a new class of cationic metallo-
polymers. Macromolecular engineering enables controlled polymerization and chemoselective
reactions, which allow the synthesis of polymers with precise compositions. These cationic
metallo-polymers can substantially enhance the efficacy of antibiotics when they are combined.
The antibiotics for antimicrobial screening include β-lactams, carbapenems, tetracyclines,
aminoglycosides, etc. We are particularly addressing persister cells in the MDR forms of Gram-
negative pathogens, such as those designated as “urgent threats” and “serious threats” by CDC.
Our approaches aim to design biodegradable polymer compositions that can install cationic
cobaltocenium at the side chain, which can target cell membranes and outer leaflets. There are
four objectives involved in this project: (1) to screen biodegradable polymer compositions for
combinations with antibiotics against stationary phase bacteria or persisters; (2) to uncover
synergistic mechanisms of action in polymer-antibiotic combinations; (3) to evaluate biofilm
eradication and inhibition of lead combinations; (4) to evaluate cytotoxicity and conduct in vivo
efficacy of infections.
Our research and discoveries could provide a new polymeric biomaterial platform to
reinvigorate common antibiotics to kill MDR bacteria.

Public health relevance
Project Narrative-Relevance to Public Health The threats by bacteria against common antibiotics is a challenging issue in treating infectious diseases. We propose a platform biomaterial technology to use macromolecular engineering for designing a class of biodegradable metallo-polymers that can reinvigorate a variety of antibiotics against multidrug-resistant Gram-negative bacteria such as Pseudomonas aeruginosa. The essential mission is to design cationic metal-containing polymers and combine them with antibiotics for targeting biological interfaces involving bacterial cell components, which will have a significant impact on advancing the development of novel antimicrobial agents and regeneration of efficacy of conventional antibiotics for the successful treatment of persister cell-associated infections.